Novel 5-HT7 Antagonists for the Treatment of Pruritus

Project Summary (Abstract)
Evidence supporting serotonin (5-HT) as a contributing factor to the severity of pruritus has been widely reported.
Elevated levels of 5-HT have been reported in patients with atopic dermatitis and chronic eczema, thus
supporting 5-HT as a contributing factor. Additionally, 5-HT invokes dose-dependent scratching when
administered via intradermal injection in rodents. Studies have demonstrated that 5-HT induces scratching
sensations by activating a subset of receptors. Substantial evidence supports a role of peripheral 5-HT7 receptors
in chronic itch via opening of the TRPA1 channel. Opening of the TRPA1 channel is reported to be required for
the manifestation of chronic pruritus. 5-HT7 is co-expressed with TRPA1 in a subset of primary afferent sensory
neurons that innervate the skin. When 5-HT7 was activated with either 5-HT or a highly selective 5-HT7 agonist
(LP-44) it triggers neuronal excitation via calcium flux thru the TRPA1 channel in a cyclic AMP dependent matter.
The involvement of 5-HT7 in pruritus was supported in vivo as intradermal administration of LP-44 into the cheek
of mice evoked significant scratching behavior that was attenuated via pharmacological blockade with a selective
5-HT7 antagonist (SB-269970). 5-HT and LP-44 induced scratching was also attenuated in either 5-HT7 or
TRPA1 knock-out mice. Additionally, 5-HT7 and TRPA1 knock-out mice displayed reduced scratching and skin
lesion severity in an atopic dermatitis model (MC903 induced) where 5-HT levels were significantly increased at
the affected site. This data suggests that a 5-HT7 antagonist could be useful for the treatment of pruritus. We
have chosen 6 highly potent, selective 5-HT7 antagonists that display peripherally restricted
pharmacokinetic (PK), good dermal penetration/permeability and safe preliminary ADMET profiles. We
hypothesize that our novel 5-HT7 antagonists will attenuate scratching in murine models of pruritus (MC903) and
provide a novel mechanism for treating pruritus. We will pursue a multipronged approach focused on identifying
novel lead compounds suitable for advanced in vivo efficacy studies.

Public health relevance
Project Narrative Pruritus, the urge to scratch due to an unpleasant sensation, is the most frequent symptom in dermatology and occurs as the result of acute or chronic dermatologic conditions. While patient relief in acute pruritus can be achieved with various topical treatments, chronic pruritus is notoriously hard to treat. It has been demonstrated that the 5-HT7 receptor play an important role in chronic pruritus and genetic ablation of the 5-HT7 receptor has been reported to be effective in chronic murine models. Using a chronic pruritus model, the project aims to develop a proof-of-concept for our novel 5-HT7 antagonists for the treatment of chronic pruritus.